Administrative Core A

ADMINISTRATIVE CORE A PROJECT SUMMARY
The overall goal of the Administrative Core is to provide administrative leadership to support the mission of the
Cleveland DDRCC. The Core supports digestive disease investigators at Case Western Reserve University
(CWRU) and the Cleveland Clinic Lerner Research Institute (CCF LRI) by 1) assuring appropriate allocation of
Cleveland DDRCC resources and providing overall financial management for the Center, 2) continuing to
develop the Center in a manner that maximizes productivity and effectiveness and strategically grows the
Cleveland DDRCC Research Base in the thematic areas of Digestive Inflammation/Tumorigenesis and Liver
Disease/Metabolism, and 3) fostering opportunities for scientific collaboration among our Center members and
development of our junior investigators. The Center Director, Dr. Fabio Cominelli, and Associate Center
Directors, Drs. Claudio Fiocchi (CCF) and Theresa Pizarro (CWRU), provide the administrative and scientific
leadership for the Cleveland DDRCC. Their leadership is augmented by the support of an Internal Advisory
Committee and an Executive Committee, which is composed of the Center directors, Core directors, Scientific
Program leaders, and two ad hoc DDRCC members. The Executive Committee meets quarterly to review all
financial and programmatic issues related to the Center. An External Advisory Committee composed of three
international leaders in the thematic areas of the Center meets annually with the Center Director and Executive
Committee to review the Center and provide critical feedback. A Center Administrator and Administrative
Assistant provide support for day-to-day financial management and operation of the DDRCC, and a Core
Consultant performs regular evaluation of the Center’s Research Base, Core services, and Center activities to
assure the Center continues to cost-effectively meet the evolving needs of its members over time. The Core
supports a clinical element directed by Dr. Gregory Cooper, which provides biostatical/study design and
bioinformatic support services to Center members, as well as a robust Enrichment Program directed by Dr.
Theresa Pizarro aimed at fostering new investigations and collaborations in digestive diseases research. The
Enrichment Program supports a DDRCC Seminar Series with research-in-progress talks by Center members
and seven visiting professors per year, partipation in the Midwest DDRCC Alliance and its annual research
symposium (hosted by the Cleveland DDRCC in 2018), the biannual Cleveland IDEAS Symposium, the
DDRCC Young Investigators Network, and strategic planning retreats with Center leadership and members.
Finally, the Administrative Core coordinates a vibrant Pilot and Feasibility Program directed by Dr. Amitabh
Chak to promote the development of junior investigators in digestive diseases. The Cleveland DDRCC has
received exceptional institutional support from the CWRU School of Medicine and CWRU Digestive Health
Research Institute, and the CCF LRI and Digestive Diseases Instititute and looks forward to continuing with its
mission over the next funding cycle.